Contact Pathway Inhibitor to Prevent Vascular Access Failure

Project Summary
End-stage renal disease (ESRD) patients must maintain chronic vascular access to perform life-saving
hemodialysis (HD); however, the HD access portal is extremely vulnerable to infection, stenosis, and thrombo-
occlusion. While vascular access options include the placement of central veinous catheters, arteriovenous
(AV) fistulas, and AV grafts, superior outcomes have been established with the use of AV fistulas (AVFs).
Despite national vascular access guidelines promoting the use of AVFs over synthetic arteriovenous grafts
(AVGs) for dialysis due to their lower occlusion rates and longer survival, AVGs are still utilized in ~17% of all
chronic HD patients (~85,000 in the U.S.). Regrettably, significant healthcare disparities exist within this patient
population. Indeed, in chronic HD patients, the rate of AVG use is 77% higher in the Black/African American
versus white population, while AVG use among females is 69% greater than in males. Thus, an important
unmet need exists to address AVG patency and longevity. This SBIR Fast-Track project directly addresses the
critical need by developing a unique antithrombotic agent, AB023 (xisomab 3G3), to help maintain chronic
AVG access patency. To this end, we have recently completed a single-dose pilot phase 2a clinical trial
(NCT03963895) in ESRD patients to evaluate whether this approach may be safe and effective. Our early
clinical data suggests that xisomab 3G3 is indeed safe in this medically complex patient population, with no
drug-related adverse events and no increased bleeding observed at the vascular access site (Lorentz, et. al.
Blood, 2021). A single dose of xisomab 3G3 limited systemic markers of both thrombosis and inflammation,
and also reduced severe dialysis circuit blood clotting events. During this proposed Phase I/II SBIR project, we
propose to extend these studies into repeat, every other week drug administration to determine if this new
approach to anticoagulation is safe and effective in chronic HD patients with AVGs, who generally have an
elevated risk of both thrombosis and bleeding and no satisfactory options for therapeutic anticoagulation. Since
xisomab 3G3 specifically targets coagulation factor XI (FXI) activation by factor XII (FXII) without inhibiting the
FXI feedback activation by thrombin, our innovative drug candidate is entirely unique in the growing
armamentarium of FXI inhibitors under development. Accordingly, since FXII deficiency in humans does not
result in any known bleeding side-effects, xisomab 3G3 could be an effective antithrombotic strategy that is
exceptionally safe. As such, xisomab 3G3 represents a fundamentally unique anticoagulation concept.
Success of the proposed research and achievement of our critical milestones will lead directly to subsequent
and definitive safety/efficacy trials in ESRD patients with chronically implanted AVGs, who are in desperate
need of safe thromboprophylaxis.

Public health relevance
Project Narrative There is a critical unmet medical need for safe blood thinning drugs that do not cause bleeding. This unmet need is especially important in kidney failure patients who require chronic vascular access to perform life- saving kidney replacement therapy via vascular access sites that are highly prone to blood clots and occlusion. The proposed research addresses this critical need by continuing the clinical development of a unique drug candidate, AB023 (xisomab 3G3), which has been shown in primate studies and early human trials to potently inhibit blood clot formation without bleeding side-effects, and therefore has the potential to safely prevent vascular access clotting and failure.